Functional Organization of the Somatosensory System

DESCRIPTION (provided by applicant): The goal of this proposal is to determine the mechanisms that mediate the extensive reactivations of somatosensory cortex and the return of hand use after large lesions of cutaneous receptor afferents in the dorsal columns of the spinal cord. Our experiments will determine if new connections are formed in the post- lesion somatosensory system, if a promising treatment with an enzyme promotes useful new connections, and if reactivated neurons in somatosensory cortex have response properties to touch on the hand that would usefully guide tactile behavior.

Public health relevance
PUBLIC HEALTH RELEVANCE: The goal of our project is to better understand how individuals recover after extensive brain damage to the nervous system, and if certain treatments promote useful recoveries. We expect that our results, based on spinal cord injury, will apply broadly in understanding how the human nervous system recovers from injuries, and suggest clinical applications that would improve recoveries.